Projective Methods for PET/SPECT Image Analysis

Project Summary/Abstract
This research proposes a new image analysis technology for PET/SPECT neuroimaging. Analysis of
PET/SPECT neuroimages often requires an image reference region where the radiotracer has non-specific
binding. Unfortunately, many old as well as emerging radiotracers do not have a useful reference region, and
this can limit their use. In this research, we propose the development of a new computational technology for
processing such images using ideas from projective geometry. This methodology will enable reference-region-
free analysis of PET/SPECT images, thereby enabling a more widespread use of tracers that do not have an
optimal reference region.
There are three specific aims to this exploratory research: The first is to fully develop the mathematics and
algorithms of the projective approach. The second is to evaluate the proposed methods using a large image
dataset of a SPECT tracer (Ioflupane) with a known reference region. This tracer is used in imaging
Parkinson's Disease. This dataset will enable the comparison of the new methods (with the reference region
ignored) with classical methods which use the reference region. Finally, we will evaluate the performance of
this method with a new PET tracer for synaptic vesicle protein SV2A. This tracer has a suboptimal reference
region; no non-specific binding region is known. The results of the reference region free method will be
compared with classic compartmental modeling.

Public health relevance
Project Narrative PET/SPECT image analysis often requires a reference region where the PET/SPECT tracer exhibits non- specific binding. There are many tracers (old and new) for which a reference region is not known. This research proposes to develop new reference-region-free analysis methods, which will make these tracers available for use in the clinic and in large clinical trials.